Resource Discovery

TR&D Project 1: Resource Discovery Abstract Our proposed BTRC resource, the Center for Reproducible Neuroimaging Computation (CRNC), seeks to implement a shift in the way neuroimaging research is performed and reported. Through the development and implementation of technology that supports a comprehensive set of data management, analysis and utilization frameworks in support of both basic research and clinical activities, our overarching goal is to improve the reproducibility of neuroimaging science and extend the value of our national investment in neuroimaging research. Reproducibility is critical because the current literature is fraught with published results that are due to mistakes (occasionally misconduct); or turn out to be false positive (contributed to by the lack of statistical power). More importantly, given the current publication system, it is exceedingly difficult to discern between false positive and true positive finding as data is hard to aggregate, and exact methods are hard to replicate. In this Technology Research and Development Project, TR&D 1: Resource Discovery, we will establish the technology for comprehensive data and software discovery. We will integrate existing successful community platforms, extend existing data and search services, and develop new search and discovery tools to create a sophisticated, comprehensive and dynamic search environment for working with distributed neuroimaging data, tools, workflows and execution environments. This work will support users in discovery and also assist the end user with a specific analytic goal in finding the appropriate available data and software that can subsequently be submitted to the specified workflows and executions environments. To accomplish this, we will: 1) Establish a comprehensive environment for search and discovery of Neuroimaging data and tools; 2) Provide automatic search and retrieval of Neuroimaging data for repeatable processing workflows; and 3) Implement “NeuroBLAST”, a tool that allows users to find matching/similar studies based on a combination of task, analysis, and activation patterns. We will work in partnership with the other TR&D projects, the Training and Dissemination Core and the Collaborator and Service Project users to deploy, test and validate the reproducible analysis system and to foster use of the reproducible framework in the neuroimaging research community.